Multiscale analysis of the mechanisms of cortical information loss in diffuse glioma

Project Summary/Abstract
Recent years have seen the simultaneous eruption of the field of cancer neuroscience and the expansion of the
role of intraoperative neurophysiological monitoring to guide safe maximal neurosurgical resection of intracranial
pathologies, including gliomas. This enables an unprecedented study of the effects of tumors on the
electrophysiological correlates of human cognition. Breakthrough translational technologies such as
microelectrode arrays and the Neuropixel probe have only improved our investigations' granularity, narrowing
the capabilities gap between rodent and human researchers. Despite the nascent ascendancy of cancer
neuroscience as a field, we know very little, in humans and generally, about the electrophysiologic mechanisms
by which gliomas affect neuronal information processing on either population or single neuron levels and how
this is affected by tumor grade and pathology. We do, however, clinically observe that cognitive dysfunction is
present in most glioma patients, which is an independent predictor of worsened outcomes, highlighting the
pressing need better to understand glioma cells’ functional integration into cortical circuits. Thus, by answering
the central question of our project proposal – what are the population and single neuron level mechanisms by
which various gliomas affect cognition? – we can potentially satisfy the dual purpose of the NINDS, furthering
our fundamental understanding of neurophysiology and generating ideas for potential novel therapeutics for
gliomas. We aim to accomplish this by administering a newly developed somatosensory discrimination task to
patients with gliomas undergoing awake brain surgery for resection while recording brain activity with both
macroelectrode grids and microelectrode arrays. We will then employ established and novel electrophysiologic
techniques to probe the electrophysiologic signature of the glioma-neuron interface. Our institutional environment
is uniquely positioned to answer these questions due to its status as an international referral center for glioma
surgery and its current nation-leading efforts in translating novel recording technologies for human intraoperative
experimentation. During my fellowship, I will participate in fine-tuning intraoperative data acquisition and have
the personnel and computing resources to perform electrophysiological analyses on the recorded signals. This
will advance my understanding of lab management, novel electrode technology, and data science, with the end
goal of increasing my capabilities of running my own lab as an independent surgeon-scientist in the near future.

Public health relevance
Project Narrative Gliomas are among the most common neurological disorders in adults, reducing not only life expectancy but also cognitive ability, an independent predictor of outcomes and quality of life. In recent years, we have enjoyed the simultaneous growth of translational recording technologies leveraged for human intraoperative studies of cognition and the field of cancer neuroscience, which is interested in uncovering the oncologic effects of the anatomic and functional integration of gliomas into neural circuits. By combining recent advances in these two fields, using humans with gliomas as a study cohort, we aim to uncover the multiscale electrophysiologic mechanisms of glioma-induced cognitive dysfunction, providing critical insights into targets for novel therapies to improve functional and oncologic outcomes.